Novel functions for NMDARs in neural crest development

The neural crest (NC)is a multipotent cell type that gives rise to a host of neural and non-neural
tissues including the craniofacial cartilage, pigments cells and the peripheral nervous system. NC
development is well-studied, and many factors regulating NC specification, proliferation and migration
have been described. We unexpectedly discovered that mutants that lack the obligatory N-Methyl-D-
Aspartate receptor (NMDAR) subunit (grin1 mutants) show excess craniofacial cartilage and melanocytes
suggesting a previously unknown role for NMDARs in non-neural NC development. NMDARs are
glutamate-gated cation channels that are critical synaptic proteins and play a key role in excitatory
neurotransmission. Almost nothing is known about NMDAR function in NC and the grin1 mutants offer
a unique opportunity to explore this connection. In our first aim, we will determine whether NMDARs
broadly modulate NC proliferation, migration or act in a subset of NC lineages. We will then assess the
mechanisms of NMDAR NC function in the second aim. Here, we will ask whether NDMARs modulate
of Ca2+ influx in NC and if NMDAR activity is required in NC or another cell type. Lastly, we will
determine which NMDAR subunits mediate the effect on NC as the composition of NMDARs is critical
to its properties as an ion channel and modulate numerous protein interactions. Our work demonstrates a
novel role for NMDARs in regulation of NC development and our proposed studies lay the foundation for
understanding the mechanisms at play. NMDAR dysfunction is associated with several
neurodevelopmental disorders include autism, epilepsy and intellectually disability. Elucidating the
activity of NMDAR in NC has implications for both unraveling underappreciated NC related phenotypes
in these disorders and for delineating NMDAR functions that may be relevant to neurocristopathies.

Public health relevance
PROJECT NARRATIVE The neural crest (NC) gives rise to a wide range of tissues including the autonomic, enteric, and peripheral nervous systems, as well as cartilage, cardiac, and pigment cells. In preliminary studies using zebrafish, we found an unexpected role for a subtype of glutamate receptor, N-methyl-D-aspartate receptors (NMDARs) in NC development. In the proposed aims, we will study the role of NMDARs in NC to illuminate NMDAR function during normal NC development and in disease states.